Alcohol Research Training in epigenetics and pathophysiology (ARTEP)

Abstract:
Alcohol use disorder (AUD) is characterized by a pattern of compulsive alcohol drinking or a loss of control
over alcohol drinking. The development of addiction involves neurobiological changes in several key brain
regions that play a role in the behavioral manifestations of ethanol dependence. Epigenetic regulation
(Histone and DNA chemical modifications) of gene expression is an important area in the field of
neuroscience that emphasizes the importance of gene interactions with environmental factors. This T32
training grant entitled “Alcohol Research Training in Epigenetics and Pathophysiology” (ARTEP) is
developed in order to directly provide training to pre-doctoral (PhD in neuroscience or psychology) and
post-doctoral fellows (PhD, MD/PhD graduates) on epigenetic and molecular processes that play a role in
the neuroadaptive and behavioral responses to ethanol as well as the pathophysiology of alcoholism. The major
objective of this T32 training grant for the NIAAA funded Alcohol Research Center entitled “Center for Alcohol
Research in Epigenetics (CARE)” at the University of Illinois at Chicago (UIC) is to provide training to young
researchers in the epigenetic basis of alcohol addiction and to develop leading addiction researchers in this
emerging field of neuroscience. Besides outstanding training in addiction research, trainees will also receive
supplemental targeted training that will include didactic courses, seminars, presentations at national and
international scientific meetings, responsible research conduct, research data handling and management
as well as manuscript and grant writing. Trainees coming out of ARTEP will become future independent
alcohol researchers to promote cutting edge research in epigenetics and neurobiology to better understand
the pathophysiology of AUD. The overarching goal of the alcohol research training program is to
provide training to young researchers in epigenetic mechanisms of molecular and behavioral
phenotypes of AUD. The objectives are: 1) To provide unified training and apply a multidisciplinary
approach by involving established investigators as faculty sponsors with expertise in areas of animal
models, human research, tissue culture, human post-mortem brain studies, neuroimaging, electrophysiology,
psychiatry, anatomy, epigenetics, molecular biology, and bioinformatics to cover a wide range of topics of
addiction. 2) To provide resources and a scientifically enriched environment for graduate students and post-
doctoral fellows for suitable training in epigenetic studies in alcoholism so these fellows become independent
alcohol researchers. 3) To provide administrative and scientific leadership to trainees and develop them to
become leading alcohol researchers. 4) To teach trainees how to prepare research grant applications (F or
K grant mechanisms), perform independent research and occupy faculty positions at universities. This
training program focusing on epigenetics is very unique in alcoholism research and will accelerate the training
of the next generation of bright young scientists and clinicians in the field of alcohol research.

Public health relevance
Alcohol use disorder (AUD) is a chronic relapsing disease that is often comorbid with psychiatric disorders and other drugs of abuse. Epigenetic mechanisms that may underlie both molecular and behavioral phenotypes appear to be important in better understanding AUD and related comorbidities. This alcohol research training grant will develop the next generation of basic and clinical alcohol researchers leading to more research in this area so that discovery leads to development of new drugs to treat or prevent AUD.